Novel neuroprotective activities of flavonoids against retinal degenerative diseases

ABSTRACT
Functional rhodopsin (Rho) composed of apoprotein opsin and covalently bound 11-cis-retinal chromophore is
required for normal phototransduction and vision. Inherited mutations compromise proper folding, binding of
11-cis-retinal, and stability of Rho, leading to retinitis pigmentosa (RP), a progressive degenerative eye
disease that causes blindness. Currently, there are no treatment options available to combat RP. Retinal-
based pharmacological chaperones and non-retinal small molecules, including flavonoids, can stabilize certain
Rho mutants in vitro. However, effective and safe therapy for RP has yet to be established. Dietary flavonoids
have been reported to show beneficial effects in ocular impairments. Our preliminary studies showed that
common flavonoid quercetin could stabilize pathogenic Rho, improve its folding, membrane integration, and
retinal binding. We also found that quercetin inhibits stress-induced cellular responses related to pathogenic
mutants triggering Bax-mediated apoptosis with beneficial consequences to retinal health.
Here we propose to study, the therapeutic potential of quercetin and its combinations with retinal analogs, and
novel small molecule Bax inhibitor to rescue RP pathology. First, we will evaluate quercetin positive effects on
RP mutants independently of the genetic background in vitro. Then, we will assess their ability to revert the RP
phenotype in vivo in mouse models of RP. To understand the underlying molecular mechanism of Rho
mutant’s stabilization offered by quercetin we will perform structural studies to delineate the architecture of
quercetin-Rho complexes by applying crystallographic and hybrid mass-spectrometry techniques. In addition,
we will search for more effective compounds stabilizing Rho mutants by high-throughput screening of
flavonoid-related compound libraries, which then will be validated with systematic biochemical and biophysical
analyses (Aim 1). Second, we will examine the role of quercetin as an adjuvant for the specific retinal analogs
stably accommodating the retinal-binding pocket. Some of these retinals improve the folding of the P23H
pathogenic Rho mutant. We will examine the potential corrective effect of new locked retinal and backbone-
modified retinal analogs for P23H Rho and determine if the binding of these retinals could be enhanced by
quercetin to gain a greater therapeutic effect in RP (Aim 2). Third, we will study the cellular processes in RP.
To gain a better understanding of RP pathology we will look for molecular targets activated by cellular stress
signals in RP and assess if quercetin can modulate these cellular processes to revert the disease phenotype
(Aim 3). At first, we will examine the effect of quercetin on Bax-mediated apoptosis to learn if its effect is
related to direct or indirect inhibition of Bax, or both. In these studies, we will also use a novel bioavailable
small molecule Bax inhibitor. We will determine the effectiveness of this new Bax inhibitor and its combination
with quercetin against Rho-related RP. Altogether, the knowledge gained from this study will pave the way to
design an effective therapeutic remedy to prevent or slow down RP pathology.

Public health relevance
NARRATIVE Progressive degeneration of photoreceptors triggered by inherited destabilizing mutations in the rhodopsin (RHO) gene and consequently activated cellular stress response triggering apoptosis cause retinitis pigmentosa (RP), currently an incurable blinding disease. Therapeutic approaches to correct these impartments focus on the development of pharmacological chaperones that stabilize Rho to prevent this retinopathy. We propose here comprehensive biochemical, structural, and animal studies to develop a novel therapeutic remedy to counter RP pathology and prevent vision loss.